ABNORMALITIES OF BALANCE AND GAIT AND SENSORIMOTOR FUNCTION IN FALLERS

Study to determine the integrity of the measurable sensorimotor components of balance, therby facilitating development of preventative measures and specific therapies.